Optimizing Use of Continuous Glucose Monitoring (CGM) to Advance Health Equity Among Youth with Type 1 Diabetes (T1D)

PROJECT SUMMARY/ABSTRACT
Use of continuous glucose monitors (CGM) has been shown to significantly improve glycemic control and
decrease the risk of complications for pediatric patients with type 1 diabetes (T1D). However, despite the rapid
advancements in technological capabilities over the past twenty years, access to and meaningful use of CGM
are not distributed equitably across the population. The continued advancement in sophistication and potential
for improved outcomes coupled with population-level increases in CGM use contributes to widening disparities
in care and makes essential an improved understanding of optimizing use of personal medical devices for T1D.
I am a public health trained pediatric endocrinologist; through this proposed K23 Award I aim to characterize
disparities based on race/ethnicity and socioeconomic status (SES) in CGM use for children with T1D utilizing
statistical analysis in disparate care settings and nationwide claims data. These analyses of the sources of
disparities will inform my pilot clinic-based intervention to narrow gaps in CGM use. This project builds upon
my research describing the experience of Hispanic caregivers of children with T1D, my analysis of
demographic predictors of metabolic control in the T1D program at Boston Children’s Hospital (BCH), and my
training in health services research and public health. This grant will enable my acquisition of new skills in time-
to-event analysis, claims-based data use, and intervention design, implementation, and evaluation. Adding
depth to my health services research methods and establishing a foundation in clinical trials, this grant, along
with the unique environment and diverse mentorship at BCH, Department of Population Medicine (DPM), and
Boston Medical Center (BMC) will position me well to begin an independent research program.
In Aim 1, I will utilize a national health insurance plan claims database to analyze personal medical device use
and acute care utilization among children with T1D with a focus on the impact of race/ethnicity and SES on
CGM prescription and adherence. In my second aim I will employ a mixed methods approach to quantify CGM
use among children with T1D cared for at a quaternary referral center (BCH) and a safety net hospital (BMC)
and conduct a qualitative assessment of barriers to consistent CGM use in Black, Hispanic, and low SES
patients at both sites to inform the development of a clinic-based intervention to improve CGM uptake and
adherence in diverse, marginalized, and low resource patient populations. In Aim 3, I will develop and pilot the
intervention informed by Aim 2 in a 6-month RCT at BCH and BMC to assess the impact of culturally effective
education and patient navigation for CGM use on disparities in its uptake and associated clinical outcomes.
I aim to establish a career as an independent physician-scientist with a background in the drivers of pediatric
T1D care and outcomes, with the long-term goal of providing equitable access to rapidly improving
technological innovations to better the lives of children with T1D. The mentorship, formal training, and research
experience that this K23 will provide will position me well to begin an impactful independent research career.

Public health relevance
PROJECT NARRATIVE The use of personal medical devices (e.g. continuous glucose monitors) by youth with type 1 diabetes as well as their potential to aid children and their caregivers to manage the daily demands of type 1 diabetes and optimize blood sugar control have rapidly expanded over the past twenty years. However, demographic (e.g. race/ethnicity) and socioeconomic (e.g. household income, parental education, and insurance) factors impact access to and continued use of such technology. The goals of this project are to better describe and analyze the interplay of such factors in sustained utilization of CGM in different clinical settings and to characterize their impact on a national level to enable the development and implementation of a pilot study designed to achieve improved equity in continuous glucose monitoring use for pediatric patients with type 1 diabetes.